Genetic Predisposition to Elevated Blood Pressure and Midlife Cognitive Function: Exploring the Impact of Lifespan Risk Factors and Polygenic Risk Scores

Hypertension (HTN) is the most common preventable and treatable condition that increases the risk for
dementia. However, RCTs for blood pressure (BP) control have shown that the benefits are highly variable from
person to person, and others have reported null findings. Polygenic Risk Scores of elevated BP (BP PRS) have
identified individuals with increased risk for hypertension (HTN), even prior to manifesting elevated BP. Despite
the disproportionate burden of elevated BP and dementia outcomes in minoritized groups, few BP PRS are
available for individuals of non-European ancestry. This K08 aims to investigate the relationship between genetic
predisposition to HTN with midlife cognitive function and Alzheimer’s Disease and Related Dementia (ADRD) in
late life, as well as its potential predictive value when combined with life course modifiable risk factors
information. The study seeks to test the hypothesis that genetic predisposition to elevated BP impacts midlife
cognitive function and dementia later in life and has added predictive value when combined with early life course
modifiable risk factors by pursuing three specific aims: Aim 1: Evaluate the association between a multi-ancestry
BP PRS and midlife cognitive function by leveraging data from the Bogalusa Heart Study (BHS). The BHS is a
unique longitudinal cohort with data from childhood on rural, low-income, Black and White, men and women
entering their 6th decade of life. Aim 2: Examine the association between multi-ancestry BP PRS and midlife
MRI-based brain markers of disease. This aim will investigate whether higher BP PRS levels are associated with
more cerebral white matter lesions and brain volumes in midlife and if these associations are modified by life
course modifiable risk factors and midlife subclinical cardiovascular indicators. Aim 3: Assess the utility of BP
PRS in predicting midlife cognition and dementia syndromes in late life by leveraging data from well-
characterized longitudinal cohorts, including CARDIA and the HRS. This aim will also determine to what extent
BP PRS enhances the predictive value of life course ADRD risk factors. The long-term goal of the candidate, Dr.
De Anda-Duran, is to become an independent investigator focusing on vascular influences on brain health
across the lifespan. The proposed project will provide training and expertise in genetic epidemiology, health
disparities, and neuroimaging methods. This includes advanced statistical techniques for analyzing genetic data,
understanding health disparities and their impact on ADRD, and using neuroimaging to study brain structure and
function. The integration of these skills will enable the identification of high-risk individuals who might benefit
most from BP control pharmacological treatments and lifestyle interventions. Successful completion of this
project will generate preliminary data for a future, large-scale multi-cohort R01 application. Findings from this
project will aid in identifying when, in the lifespan, BP control and lifestyle modification interventions might be
more beneficial and shed light on effective multidomain approaches to significantly reduce ADRD risk.

Public health relevance
This study will assess the impact of genetic predisposition to high blood pressure and life course risk factors on midlife cognitive function neuroimaging markers and Alzheimer's Disease Related Dementia (ADRD) syndromes.